STUDIES OF THE ANEMIA OF CHRONIC DISORDERS AND MALIGNANCY

Correlation of the severity of anemia of chronic disease with tumor type, response to radiation, and levels of plasma interleukin and tumor necrosis factor in patients with malignancy.